Development of first-in-class antagonists of the retinoid pathway as novel oral therapies for Type 2 Diabetes

Project Summary:
The retinoid pathway is a central regulatory pathway in human biology that has been considered
undruggable for the last 20 years. It is activated when dietary vitamin A is transported to target tissues,
is oxidized to all-trans retinoic acid (atRA), and then binds the RARα/β/γ nuclear receptors. This binding
results in transcriptional regulation that is best known to influence the differentiation state of various
cells and tissues. In metabolic disorders, ALDH1a3 is a key enzyme responsible for the final synthetic
step of the retinoid ligand, and has also been identified as one of the principal pancreatic β cell markers
for Type 2 diabetes. Numerous studies have shown that ALDH1a3 protein levels or enzymatic activity is
a specific marker for failing/dedifferentiated β cells that lose the ability to produce insulin in Type 2
diabetics. Whereas retinoid signaling has long been a pathway of interest in both rodent and human
diabetes, published studies have not established whether or not retinoid signaling and thus ALDH1a3
are drivers of Type 2 diabetes.
Our initial discovery work suggests that ALDH1a3 is a driver of the β cell dedifferentiation
observed in Type 2 diabetes and thus may offer a target whose inhibition can offer durable treatment
effects for diabetics. Discussions with stakeholders across the Type 2 Diabetes community have
demonstrated considerable interest in disease-modifying therapies that restore pancreatic function as
there is broad recognition that current therapies are limited in activity to controlling blood glucose levels
and insulin sensitivity rather than affecting pancreatic health. Thus, to reverse the projected rise of Type
2 diabetics across the world, next generation drug combinations are needed that restore pancreatic β
cells to their normal differentiation status.
Utilizing proprietary chemistry platforms, Kayothera is the first group to have developed lead
inhibitors against ALDH1a3 that show exceptional potency and specificity while avoiding the
pharmacologic liabilities of other drug development programs in the retinoid pathway. Our therapies
show strong potency in inhibiting the retinoid pathway (<5 nM cellular, a 200-fold improvement over
published molecules), no off-target activity, high metabolic stability, excellent oral pharmacokinetic
properties and promising in vivo toxicology. Here we propose to nominate an IND development
candidate through dose-range finding studies and PD/efficacy models. The results of this research
proposal will advance a first-in-class therapy toward clinical testing with the aim of restoring pancreatic
health to millions of patients in need.

Public health relevance
Project Narrative: This project advances a novel therapy that targets a clinically important yet previously undruggable pathway that may be disease-modifying in Type 2 Diabetes. Kayothera has developed this first-in-class therapy using a next- generation drug discovery platform based on discoveries from Princeton University. Specific aims outlined in the grant will provide the basis for advancing this therapy to IND-enabling experiments through a series of pharmacokinetic and pharmacodynamic assays.